GLYCEMIC CONTROL TO RENAL SALT BALANCE IN DIABETES MELLITUS

To determine if the level of control of blood sugar thus the filtrated load of glucose delivered to proximal tubules contributes to the salt- expanded state commonly seen in insulin-dependent diabetes mellitus. To examine influence of insulin and glucose loads on glomerular hemodynamic changes found in insulin-dependent diabetes.